Postdoctoral Rheumatology Training

This proposal is a competitive renewal of a National Research Service Award for Rheumatology Research
Training at Northwestern University Feinberg School of Medicine. This request responds to the ongoing,
compelling need for Rheumatology research training by providing organized leadership and infrastructure for
rigorous mentored research and didactic experiences, all of which have proven to be successful in the current
funding period. The program builds on the strengths of current training initiatives in basic, clinical,
translational, public health and health services research and on the considerable scientific and research
training experiences of the Rheumatology faculty and collaborators from a wide variety of medical school
departments, centers, and institutes. This request for renewal of the T32 in Rheumatology research comes at
a time of substantial and sustained growth in the research enterprise of Feinberg School of Medicine, and
ongoing growth within the division.
The long-term, overriding, goal of this training program is to nurture bright, enthusiastic, well-trained,
academically-oriented M.D.s and Ph.D.s in their pursuit of a career in Rheumatology investigation, by enabling
them to synthesize information about the complex issues associated with conducting scientifically and ethically
sound research, and to maximize the likelihood that they will be competitive in seeking subsequent,
independent research support. The specific objectives of this training grant are: (1) to develop clinical and
basic research scientists, who will ultimately be capable of independently performing hypothesis-driven
research that addresses the needs of our target patient populations; (2) to provide stipend support and
protected time for these research trainees; (3) to sustain and improve an administrative structure that
enhances the training environment; (4) to provide both basic and clinical science trainees a rigorous base of
classroom study and experiential learning in the disciplines necessary for successfully conducting research
relevant to disease etiology, pathogenesis, outcomes, and for the provision of innovative care to patients with
arthritis, musculoskeletal, and autoimmune disorders, which is our mission; (5) to maintain an ongoing
evaluation process, modifying the program when appropriate to fully meet its aims and objectives.

Public health relevance
There is a critical need to train highly competent M.D. and Ph.D. investigators to conduct patient-centered research leading to improved understanding of the pathogenesis of and care for patients with arthritis and related conditions. The shortage of clinical research trainees has reached crisis proportions in academic medicine and this urgent situation is especially pertinent for Rheumatology research trainees. The long-term, overriding, goal of the Northwestern University Rheumatology Research Training Program is to nurture motivated, bright, enthusiastic, well-trained, academically-oriented M.D.s and Ph.D.s to advance their careers in investigation focusing on Rheumatologic and autoimmune diseases, enabling them to become the next generation of leaders in the field.